Rickettsial CspA proteins and host microRNAs in exosome formation and pathogenesis

Abstract
Rickettsioses are devastating human infections that present major public health concerns and challenges.
Microvascular endothelial cells (ECs) are the primary targets of Rickettsia infection; vascular dysfunction in the
brain and/or lungs can lead to fatal outcomes. Despite the global distribution and climate change-related
emergence of Rickettsia spp., there are sizable knowledge gaps in our understanding of the pathogenic
mechanisms of rickettsioses. Using diverse sources of EC-derived exosomes (Exos) collected during R. parkeri
infection, we have previously shown that: i) the endothelia can efficiently uptake Exos in vivo; ii) the functions
of Exos seem to be linked to their RNA cargos; iii) microvasculopathy-related microRNA (miR23a, miR30b) are
selectively sorted into Exos (using infected human umbilical vein EC); iv) only miR23a-27a-24 cluster and
miR30b, but not other tested ones, are selectively enriched in Exos (using infected human dermal microvascular
EC); and v) exosomal targeting of miR23a during infection ameliorates microvascular dysfunction. While
common sequence motifs seem to be shared exclusively among the miR23a cluster and miR30b, the selective
enrichment mechanisms remain unclear. We have recently detected rickettsial cold shock protein A (CspA) in
Exos, in association with miR27a. Our findings led to the central hypothesis that rickettsial CspA functions as
exosome-specific RNA-binding protein (exoRBP) for miR23a/27a/24/30b, regulating selective enrichment of
these detrimental exosomal miRs in R. parkeri infection. Building upon our published and established in vitro
and in vivo systems, we will test our hypothesis via two independent specific aims. Aim 1 will determine if R.
parkeri CspA can act as an exoRBP to selectively enrich exosomal miR23a/27a/24/30b during infection. We will
first use cell-free Exo-biogenesis assays with recombinant CspA protein to assess its functional role during
miR23a/27a/24/30b loading in Exos. We will then use a miR27a-knockout cell model to examine exosomal
expression levels of CspA in complex with miR27a following infection. Aim 2 will assess the biological outcomes
in recipient ECs following exposure to pathogenic Exos, or modified Exos with either ectopic expression or
deletion of rickettsial CspA. Such complementary gain-vs-loss function approaches will ensure meaningful
outcomes for our functional studies. Our research goal is to provide novel and supportive evidence for an
emerging paradigm of rickettsial virulence, namely rickettsial proteins can function as exoRBPs for selective
package of specific miRs into infected host cell-derived Exos. Research for exosome-based intercellular
communications among infected and bystander ECs in the context of vascular dysfunction is highly significant
not only for rickettsioses, but also for other vascular-targeted bacterial and viral infections.

Public health relevance
PROJECT NARRATIVE Rickettsia can cause vascular malfunction and fatal human infections. Our findings of endothelial cell-derived exosomes justify continued research to define what rickettsial proteins are selectively enriched in such exosomes and how host-bacterium interactions influence vascular function during infection. Our new discovery will be relevant to other pathogens that target the human vascular system.